eDyNAmiC (extrachromosomal DNA in Cancer) - Understanding the biology of ecDNA generation and action, and developing new ways to target these mechanisms in cancer

Abstract: eDyNAmiC (extrachromosomal DNA in Cancer)
Human genes are arranged on 23 pairs of chromosomes, but in cancer, tumour-promoting genes can free
themselves from chromosomes and relocate to circular, extrachromosomal pieces of DNA (ecDNA). These
ecDNA do not follow the normal “rules” of chromosomal inheritance, enabling tumours to achieve far higher
levels of cancer-causing oncogenes than would otherwise be possible, and licensing cancers with a way to
evolve and change their genomes to evade treatments at rates that would be unthinkable for human cells. The
altered circular architecture of ecDNAs also changes the way that the cancer-causing genes are regulated and
expressed, further contributing to aggressive tumour growth. These unique features make ecDNA-containing
cancers especially aggressive and difficult to treat. Cancer patients whose tumours harbour ecDNA have
markedly shorter survival. Despite being first seen over fifty years ago, the critical importance of ecDNA has
only recently come to light, and the scale of the problem is substantial. ecDNAs are present in nearly half of all
human cancer types and potentially up-to a third of all cancer patients. The collective current understanding of
how ecDNA form, how they function, how they move around the cell, how they evolve to resist treatment, how
they impact the immune system, and how they can be effectively targeted are lacking. We bring together an
internationally recognized, pioneering interdisciplinary team of cancer biologists, geneticists, computer
scientists, evolutionary biologists, mathematicians, clinicians, and patient advocates to boldly create novel
insights and resources and to provide transformative solutions to one of Cancer’s Grand Challenges. A core
team of experienced and productive ecDNA investigators will work with new investigators in the ecDNA and
cancer fields to bring completely new perspectives and approaches to this daunting challenge. By bridging
cutting-edge and diverse approaches and insights from cancer genomics, yeast genetics, epigenomics,
artificial genome synthesis, longitudinal patient tracking, combinatorial and machine learning algorithms,
mathematical modelling, immunobiology, and innovative chemistry we will develop a new understanding of the
role of ecDNA in cancer, and we will find new ways to drug the undruggable. This bold programme, which
consists of 7 work packages and a committed international infrastructure, generates new and unusual
collaborations that would simply be impossible under any other type of funding mechanism. Our programme
endeavours to foster bold innovative solutions to one of the hardest problems in cancer and to one of the
greatest challenges facing cancer patients.